Translational medicine and mechanistic studies of brain neurophysiology in Fragile X Syndrome

Our Administrative Core was designed to support and facilitate the scientific missions of our proposed Center
entitled “Translational Medicine and Mechanistic Studies of Brain Neurophysiology in Fragile X Syndrome”.
This Core will provide a centralized administrative body to ensure project interrelatedness and a governance
structure required for a large multi-project, multi-site Center program. Our Administrative Core will also
organize our diverse advisory committees including an Internal Advisory Committee, External Advisory
Committee, and a Family Advisory Council. The core will also allocate and coordinate activities of our multi-
project Core Scientists in the areas of electrophysiological data analysis, translational behavioral and cognitive
testing methods across species, and statistics. Providing centralized scientific resources in these areas will be
invaluable to assuring the synchrony and interrelatedness among Projects, and our ability to compare their
results. With input from program staff, we took the step of housing these scientific resources in this Core to
ensure that their contributions are coordinated at the level of the Center by the scientific leaders comprising the
Core Steering Committee to optimize achievement of our primary scientific missions. The Administrative Core
will coordinate research dissemination to the FXS family community, and the sharing of research results and
methods to the scientific community. Finally, our Administrative Core will coordinate and support the training of
clinical and preclinical students and professionals specifically to support future generations of clinical providers
and preclinical and translational researchers in the field.